Manipulating b1 integrin to enhance radiation therapy for breast cancer

DESCRIPTION (provided by applicant): Historically, research has focused on the ability of ionizing radiation (IR) to eradicate the tumor by eliminating cancer cells through DNA damage and apoptosis. However, as we have pointed out in a recent review, the global consequences of IR on the normal tissue microenvironment can also have important clinical implications. Extracellular matrix (ECM) has been shown to mediate signaling through its receptors such as β1 integrin and is critical to maintenance of normal tissue structure, a feature that is fundamentally disrupted in the malignant phenotype. ?β1 integrin signaling has been implicated in breast cancer progression, and, in addition, has been shown to facilitate resistance to chemotherapy and IR in several human cancers. We have shown previously that β1 integrin expression is aberrantly up regulated after IR exposure in a heritable and persistent manner in mammary epithelial cells cultured in a 3-dimensional laminin rich matrix (3D lrECM). My initial studies have shown that β1 integrin inhibition resulted in enhanced apoptosis and decreased proliferation among breast cancer cell lines in the 3D lrECM culture model and in vivo with no discernible toxicity to animals. Importantly, in a study of early stage invasive breast cancer patients, we found that increased β1 integrin expression was prognostic for recurrence-free and overall survival at 5 and 10 years (Appendix IV). In the present proposal, our preliminary data demonstrates that β1 integrin inhibition enhances the therapeutic efficacy of IR in 3DlrECM and in vivo;these promising findings have the potential to impact clinical RT for patients. We hypothesize that β1 integrin mediates a pro-survival signal after IR via Akt that can be targeted for therapy. The primary focus of this proposal therefore will be to investigate if IR induced β1 integrin signaling mediates a survival signal via Akt using 3D lrECM culture models of invasive breast cancer and ductal carcinoma in situ (DCIS) and to expand upon the Akt-mediated survival effects of β1 integrin signaling post-IR in the context of the tumor microenvironment in vivo.